A Pilot Study to Evaluate the Anabolic Effect of Testosterone on Muscles of the Pelvic Floor in Older Women with Stress Urinary Incontinence

PROJECT SUMMARY
Female pelvic floor disorders (PFD) which include urinary incontinence (UI) are a major public health problem
affecting women of all ages in the United States with significant negative impact on quality of life. Stress
urinary incontinence (SUI), the most common type of UI, is defined as the complaint of involuntary urine
leakage on effort or exertion, including coughing, sneezing or lifting. Pelvic floor integrity is an important
predictor of SUI. The pelvic floor musculature is involved in the support of pelvic organs and micturition.
Voluntary contractions of these muscle groups enable control of the urethral sphincter to maintain urinary
continence during stress maneuvers. SUI results from weakness of the pelvic floor musculature, fascia and
ligaments. Recent studies have shown that androgens may play an important role in pelvic floor and lower
urinary tract integrity, as the muscles in these structures are androgen-sensitive and express large numbers of
androgen receptors in both animals and humans. In preclinical models, exogenous testosterone administration
results in greater increases in pelvic floor muscle mass compared to any other skeletal muscle group,
underscoring the high sensitivity of this muscle to androgens. In female animal models of experimentally-
induced SUI, testosterone therapy increases pelvic floor muscle mass and improves urodynamic parameters.
Observational studies in women with polycystic ovary syndrome who have high testosterone levels show both
greater pelvic floor muscle mass and strength as well as fewer UI symptoms compared to controls. Taken
together, these data suggest that testosterone has direct anabolic effects on pelvic floor muscles which may
provide a therapeutic option in women with SUI. The anabolic effect of testosterone supplementation on pelvic
floor muscles in patients with stress urinary incontinence has not been studied in women.
The overall goal of this proposal is to evaluate the efficacy of testosterone supplementation in increasing the
muscles of the pelvic floor in a double-blind, randomized-controlled trial in older postmenopausal women with
stress urinary incontinence. We will also assess the efficacy of testosterone supplementation on urodynamic
function, urinary symptoms and quality of life. We propose a 12-week double-blind, randomized-controlled,
proof-of-concept trial to determine the efficacy of testosterone supplementation versus placebo in women age
60 years and older with stress urinary incontinence. The following outcomes will be measured: 1) pelvic floor
muscle volume with pelvic magnetic resonance imaging, 2) urodynamic function with urodynamic studies, and
3) urinary symptoms and quality of life. Current treatments available for female SUI center largely on surgical
interventions and few seek to restore integrity to the dynamic supports of continence. Thus, there is a clear
need for innovation to provide a wider range of effective treatment options for women with SUI. If this trial
confirms benefits of testosterone therapy, female patients with SUI will have an inexpensive, relatively safe and
easy to administer medication available that has the potential to transform the care of these patients.

Public health relevance
PROJECT NARRATIVE Stress urinary incontinence is the most common female pelvic floor disorder encountered in clinical practice with significant negative impact on quality of life. The prevalence of urinary incontinence increases with aging, and weakness of the pelvic floor muscles contributes to the development of stress urinary incontinence. Given that androgen receptors are expressed throughout the pelvic floor, the anabolic effects of androgens on pelvic floor muscles may provide a therapeutic option in women with stress urinary incontinence. We propose a randomized, double-blind, placebo-controlled proof-of-concept trial in older postmenopausal women with stress urinary incontinence to assess whether testosterone therapy can increase pelvic floor muscles and improve urinary function.